Mechanisms of Smoothened Activation in Hedgehog Signaling

PROJECT SUMMARY/ABSTRACT
MECHANISMS OF SMOOTHENED ACTIVATION IN HEDGEHOG SIGNALING. The Hedgehog (Hh) signaling
pathway coordinates development in humans and most metazoans. In adult tissues, aberrant Hh pathway
activation drives various cancers, including basal cell carcinoma of the skin and pediatric brain
medulloblastoma. An unusual mechanism enables Hh signal transduction. In the basal state, the transporter-
like molecule Patched1 (PTCH1) represses Smoothened (SMO), a seven-transmembrane protein. Hh inhibits
PTCH1, which unleashes SMO activity causing downstream transcription. A leading mechanistic hypothesis is
that cellular sterols activate SMO, but are sequestered by PTCH1 in the absence of Hh. Connecting the
putative transport function of PTCH1 to SMO activation remains one of the central mysteries in understanding
how the Hh signal is transduced across the membrane. A critical gap is how, and which, sterols directly
influence SMO activation. This proposal will address these questions in two aims. The first aim focuses on
which sterols activate SMO. Here, we will combine biochemistry, structural biology, and signaling studies to
define which sterols can activate SMO and how they do so. In the second aim, we focus on how sterol binding
to distinct sites on SMO influences Hh pathway activity. We will use X-ray crystallography, cryo-electron
microscopy, and NMR spectroscopy to generate an integrated high-resolution perspective on where sterols
bind to SMO, and how they influence SMO activity. These studies will provide a mechanistic picture on how the
Hh signal is transduced across the membrane. Such insights may enable the design of SMO inhibitors less
susceptible to tumor resistance or Hh pathway modulators for regenerative medicine.

Public health relevance
PROJECT NARRATIVE The precise patterning of cells that make up most complex organisms relies on an ancient cellular communication strategy called the Hedgehog signaling pathway. This pathway is absolutely critical to the development of organisms as diverse as sea squirts to humans, and disruption in normal signaling causes many cancers. This research program will uncover the fundamental mechanism that enables cells to sense the Hedgehog signal, laying the foundation for the discovery of drugs for regenerative medicine and various cancers.